National Clinical Trials Network Research at the University of Wisconsin

Project Summary/Abstract
The University of Wisconsin Carbone Cancer Center (UWCCC), its leadership, and its faculty are
driven by a mission to defeat cancer through rapid application of groundbreaking research in
cancer education, prevention and treatment. Embedded in the UWCCC’s strategic plan are tactics
for expanding a modern research platform inclusive of a comprehensive clinical research program
with exemplary data management and clinical trial prioritization as well as scientiﬁc oversight and
leadership. The UWCCC NCTN LAPs multi-disciplinary team remains an integral component of this
strategic initiative and collaborates with key faculty to support innovative translational research for
next generation clinical trials within the NCI’s National Clinical Trials Network.
Since 1974, UWCCC faculty have functioned as leaders in the development of the NCI cancer
cooperative group program; ﬁrst within ECOG and then with RTOG, ACOSOG and GOG in the early
2000s. As the NCI and its NCTN transitioned to a centralized infrastructure in 2014, the UWCCC
designed a LAPS team of collaborative principal investigators by combining the existing broad
scientiﬁc leadership from three of the primary cooperative groups (ECOG/ACRIN, NRG and
ALLIANCE). This multi-disciplinary approach with leaders from Surgical, Medical, Radiation and
Gynecologic Oncology, facilitated an innovative governance structure to provide leadership and
oversight in prioritization of Phase II/III clinical trials, timely trial activation and robust accrual as
well as the development of junior faculty interested in oncologic clinical research. In the four years
since our last grant submission, the UWCCC LAPS team has provided support for the important
genomically-directed clinical trials as well as those with a focus on advanced imaging, while
strengthening our Cancer Center’s infrastructure.
This UG1 application seeks support for continuing the NCTN activities within the UWCCC. This
partnership remains an important mechanism for providing a diverse population of cancer patients
with novel treatment approaches, as well as a means for providing resources and support for
existing and new leaders within the NCTN to bring innovative translational projects to Phase II/III
clinical trials.

Public health relevance
Project Narrative The University of Wisconsin Comprehensive Cancer Center (UWCCC), in collaboration with the National Clinical Trials Network (NCTN), seeks to bring innovative cancer treatment trials to the population of Wisconsin and its neighboring regions to reduce the burden of cancer. Through leadership in the NCTN Cooperative group program, the UWCCC faculty are working to design the next generation of genomically-directed clinical trials, as well as those that utilize advanced imaging techniques.